Isolated Abnormality in the Diffusion Capacity for Carbon Monoxide in People Living with HIV – Epidemiology, Etiology and Pathogenesis

Project Abstract/Summary
People with HIV (PWH) have a high burden of respiratory symptoms due to chronic lung disease, of which
COPD, diagnosed by spirometric obstruction on pulmonary function testing (PFT), is best studied. The most
common finding on PFTs, however, is an abnormal diffusing capacity for carbon monoxide (DLco) with normal
spirometry, or iso↓DLco. The clinical relevance of the iso↓DLco PFT phenotype is not known. Iso↓DLco is more
common in PWH than in the general population, and HIV is an independent risk factor for reduced DLco.
Preliminary work from our lab has shown that PWH with iso↓DLco have an increased respiratory symptom
burden compared to PWH with normal PFTs. Iso↓DLco is also associated with a unique set of plasma
inflammatory/immune biomarkers compared to other PFT phenotypes like spirometric obstruction, suggesting
that the iso↓DLco PFT and biomarker pattern has a unique clinical correlate. The pathophysiology underlying
this finding is not known but may be related to early structural lung disease (emphysema or interstitial lung
disease) or pulmonary hypertension. Alternatively, iso↓DLco may be a sequela of chronic inflammation in the
setting of long-standing HIV infection and possibly co-infection with other viruses like cytomegalovirus (CMV),
which affect HIV persistence and immune activation. The central hypothesis for this study is that iso↓DLco is a
unique HIV phenotype, possibly mediated by CMV-induced vasculopathy. The study will be nested within I AM
OLD-DA, an established longitudinal cohort of PWH in San Francisco, USA and Kampala, Uganda, and will
leverage the existing research infrastructure. In San Francisco we will use advanced imaging analyses of chest
CTs to understand the etiology and potential causes of iso↓DLco. In Aim 1, we will evaluate CTs for emphysema,
interstitial lung disease, pulmonary hypertension and air trapping; based on our pilot study, we expect that in
about half of the PWH with iso↓DLco, imaging analysis will not identify a reason for the PFT finding. In Aim 3,
we will test for association between iso↓DLco, CMV and distal pulmonary vascular remodeling (‘vascular
pruning’) using quantitative CT methods with a working hypothesis that CMV-mediated vascular pruning is
associated with iso↓DLco. In Kampala, Uganda, we will study a demographically and clinically distinct cohort or
PWH and HIV-negative controls to determine the prevalence of iso↓DLco and its associated respiratory symptom
burden (Aim 2). Altogether, the results from this study will help generate a deeper understanding of this PFT
phenotype and determine if CMV is a modifiable risk factor for iso↓DLco and a target for therapeutic intervention.
Completion of this project will also provide a platform for training Dr. Katerina Byanova, a pulmonary and critical
care fellow at the University of California San Francisco, in the conduct of high-quality, patient-oriented clinical
research. This grant will provide Dr. Byanova with the support necessary to acquire the knowledge and skills to
become an independent clinical investigator and a leader in HIV-related lung disease.
.

Public health relevance
Project Narrative Chronic HIV infection leads to significant respiratory morbidity as well as irreversible changes on lung function testing; of those, isolated abnormality in the diffusing capacity for carbon monoxide in the context of normal spirometry, iso↓DLco, is the most common abnormality. Iso↓DLco as a lung function phenotype in HIV is incompletely understood though it is associated with increased respiratory symptom burden and a unique pattern of inflammation and immune activation. The purpose of this study is to characterize the epidemiology, etiology, and the possible contributors to the pathogenesis of iso↓DLco, so that specific therapies can be designed to reduce respiratory symptoms and improve the quality of life for people living with HIV.